Regulation of kinesin motors

Purpose I am requesting an administrative supplement for funds to cover unanticipated expenses that are within the original scope of two awards, GM070862 and GM116204. The unanticipated expenses are for a) outdated equipment that are essential for the project and cannot be updated and b) new technologies that were not available when the parent grant application was submitted but will advance our ability to accomplish the originally approved objectives and purposes.

Public health relevance
Project Narrative - Regulation of kinesin motors Defects in intracellular transport processes, including mutations in kinesin and dynein motor proteins, are known to contribute to neurodegenerative diseases, cancer, and ciliopathies. This work will reveal basic structure/function mechanisms that enable processive transport by kinesin motors as well as family- specific adaptations that result in functional variation important for intracellular transport processes. This work will advance our understanding of kinesin motor function and impact our ability to treat human disease. Project Narrative - Structure and Function of the Ciliary Pore Complex Recent studies have suggested that defective function of a cellular organelle called the cilium leads to human diseases (ciliopathies) with diverse pathological phenotypes across organ systems. The aim of this proposal is to study mechanisms that control the gated entry of components into this organelle. We propose that the machinery that controls protein movement into cilia is similar to that which controls transport into and out of the nuclear compartment